Targeting the HER Family in KRAS Mutant Colorectal Cancer

ABSTRACT
It is estimated that more than 53,000 people in the U.S. will die of colorectal cancer (CRC) in 2024 with an
alarming incidence and mortality rate especially among individuals younger than 50 years old. About 41% of
colorectal cancer patients have a KRAS mutation. This small protein acts as molecular switch, transitioning from
an active (GTP-bound) to an inactive (GDP-bound) state. In the past two decades with advances in drug
discovery, therapeutic modeling, medicinal chemistry, genomic sequencing, and pre-clinical validation, the once
undruggable KRAS became druggable with small molecule inhibitors targeting KRASG12C demonstrating efficacy
and clinical trials underway with KRAS inhibitors. However, responses occur only in a fraction of patients and
among responders, resistance invariably occurs. We have found that there is a striking increase in total HER2
and HER3 levels in CRC cells and patient-derived organoids (PDOs) bearing KRASG12D mutations when treated
with the KRASG12D inhibitors MRTX1133 and RMC-9805. This adaptive response could limit the efficacy of KRAS
inhibitors. We present preliminary data herein that genetic knockdown of both KRAS and HER3 in CRC cells
bearing hotspot mutant KRAS results in a statistical reduction in cell proliferation in comparison to genetic
knockdown with only KRAS or HER3. The proposal examines novel treatment strategies of a combination of
KRAS inhibitor with a HER3 antibody-drug conjugate containing the payload exatecan. Exatecan is a more
potent topoisomerase I inhibitor over SN-38 or DXd and is less susceptible to efflux by the multidrug resistance
transporters of the ATP-binding cassette family. Based on our preliminary data and colorectal cancer patient
analysis, we hypothesize that colorectal cancers use HER and mutant KRAS to optimize oncogenic signaling, at
a baseline and upon treatment with KRAS inhibitors. The objectives are to determine if co-targeting HER3 and
KRAS is efficacious in KRAS mutant CRC and delineate adaptive responses to treatment. We will test this
hypothesis using the following two aims: 1) To determine the efficacy of co-targeting HER and KRAS in CRC
cell lines and patient-derived xenografts (PDXs); 2) To determine the adaptive response in PDXs treated with
pharmacological inhibitors of KRAS and HER by exome, transcriptome, and molecular analysis. Our goal is to
expand our initial studies in vitro co-targeting mutant KRAS and HER to in vivo studies in PDXs using
pharmacological inhibitors of KRAS and HER. Molecular profiling of patients’ tumors is commonplace in the
clinic, and more patients with KRAS-mutant and HER3-mutant cancers are being identified than ever before.
There are currently no approved therapies for this CRC subtype. Thus, we aim to identify the most effective
treatment options for this population. Since several KRAS and HER family inhibitors are already approved for
use in patients with cancer, these studies have the potential to be rapidly translated to the clinic. Further, these
studies will increase our basic understanding of KRAS and ERBB receptor-driven tumor progression, which can
be applied to a larger number of human cancers.

Public health relevance
NARRATIVE Despite treatment advances targeting mutant KRAS, colorectal cancer in the metastatic setting is typically incurable. Inhibition of KRAS increases HER3 levels that could limit the efficacy of KRAS inhibitors. These studies could identify the most effective treatment strategies for patients with KRAS mutant tumors and increase our basic understanding of KRAS and HER receptor-driven tumor progression.